Tract-based benchmarking of limbic abnormalities in temporal lobe epilepsy

PROJECT SUMMARY
Epilepsy patient care faces significant challenges, with nearly one-third of patients experiencing
drug-resistant seizures and half of those undergoing surgery continuing to have seizures post-intervention.
Current diagnostic and treatment paradigms primarily rely on qualitative assessments of brain structure and
function, often focusing on grey matter abnormalities. Often overlooked is the critical role of white matter
tracts, long-range bundles of axons which support neural synchrony and excitability. Disruptions in white
matter organization have been implicated in various neurological conditions, including epilepsy. This growing
body of evidence emphasizes the value of studying white matter tracts to elucidate principles of brain
organization and offer new insights into disease mechanisms and intervention targets. The goal of this
proposal is to provide me with training on state-of-the-art white matter tractometry techniques
that will be used to interrogate structural and functional disruptions in temporal lobe epilepsy
(TLE). This training will allow me to test the hypothesis that structural abnormalities in the mesial limbic
tracts of TLE patients relate to functional disruptions and can be jointly leveraged to delineate epileptogenic
networks with enhanced neuroanatomical specificity and generalizability. The project is divided into two main
aims. Aim 1 focuses on characterizing atypical tract-based macro- and microstructure in TLE patients using
advanced diffusion-weighted MRI techniques. This will involve quantifying deviations from typical structural
variability in unilateral TLE patients, with a particular focus on the mesial limbic system. Aim 2 will investigate
atypical limbic tract functional connectivity in TLE using functional MRI, assessing how structural
abnormalities relate to disruptions in functional connectivity. By integrating multiscale structural and
functional measures of both grey and white matter, this research aims to provide a more comprehensive
understanding of epileptogenic networks than conventional methods. The insights gained from these aims have
the potential to advance our understanding of structure-function relationships in epilepsy and support the
development of more precise, personalized diagnostic and treatment strategies for focal epilepsies.
Furthermore, this work could lay the foundation for future studies on tract abnormalities in other neurological
disorders, carrying potential to inform novel interventions such as targeted tract resections or
neuromodulatory therapies.

Public health relevance
Project Narrative This proposed work addresses the critical need for improved diagnostic and treatment strategies in epilepsy by investigating the role of white matter tract abnormalities in temporal lobe epilepsy (TLE). By employing advanced neuroimaging techniques to characterize structural and functional disruptions in mesial limbic white matter tracts, this research aims to provide a more comprehensive understanding of epileptogenic networks than conventional methods. The insights gained from this study have the potential to inform more precise, personalized interventions for epilepsy patients and lay the foundation for future research on tract abnormalities in other neurological disorders.